The changing landscape of human and zoonotic malaria in Southeast Asia

Abstract
Overall
The epidemiology of malaria in Southeast Asia (SEA) is multifaceted and rapidly evolving, marked by immense
spatial heterogeneity in disease distribution across different regions and countries. As SEA countries strive to
eliminate malaria, they encounter unique challenges, including the transition from P. falciparum to P. vivax and
persistent malaria-endemic areas that are remote and exhibit rich ecological diversity. Additionally, the
emergence and rapid spread of human P. knowlesi infections in Malaysia and Thailand are serious concerns
that necessitate integration into the elimination program. This new iteration of the International Centers of
Excellence for Malaria Research (ICEMR) program builds on the groundbreaking scientific discoveries of its
predecessors (ICEMR 1&2), which has fostered international collaborations among researchers from academic
institutions in Thailand, Malaysia, Japan, and the United States. The program's primary aim is to comprehend
the intricate interplay between malaria epidemiology and vector biology in SEA, with a particular emphasis on
the dynamics of human and zoonotic malaria transmission, to inform strategies for malaria elimination. To
achieve this, research sites across Thailand and Malaysia have been meticulously selected to encompass
diverse landscapes and malaria transmission patterns. The research program consists of two interdependent
projects, with Project 1 probing the epidemiology of malaria in Thailand and Malaysia, and Project 2 scrutinizing
the impact of vector biology on the transmission dynamics of both human and zoonotic malaria in these countries.
By analyzing malaria parasite distribution and transmission dynamics in human populations, Project 1 seeks to
glean insights into disease heterogeneity, clinical outcomes, and to identify new antigens for improved diagnostic
tests. Project 2 seeks to improve our understanding of the vectorial system and its role in malaria transmission
in SEA, by examining vector community structure, population genetics, vector-parasite interactions, and vector
control tools related to human and zoonotic malaria. Both projects will be executed concurrently at selected study
sites across two countries in SEA (Thailand and Malaysia), focusing on border regions where active malaria
transmission is ongoing. The program's multidisciplinary approach, which blends epidemiology, vector biology,
and advanced diagnostic tools, aims to devise integrated control strategies tailored to SEA's distinctive
challenges. The outcomes of this program will inform policy decisions related to malaria control and elimination,
ultimately contributing to efforts to reduce the burden of this disease in the region.

Public health relevance
Overall Narrative The forests and plantations of Southeast Asia form a complex and rich ecology that is home to all major malaria parasite species of public health importance. This study will use state-of-the-art tools in genetics, serology, parasitology, and vector biology to tackle current challenges confronting the malaria-elimination effort in this region, focusing on the factors underlying disease transmission and the rapid spread of Plasmodium knowlesi, a malaria parasite of monkeys that often causes severe and fatal infections in humans. The expected outputs of this project range from fundamental knowledge underlying parasite virulence and transmission to new diagnostic tools for point-of-care and surveillance applications.